Software for collaborative construction, simulation, and analysis of mechanistic computational models of biological systems

Project Summary
The parent grant, 2R35GM119770, (“Multi-cellular and multi-scale systems modeling to understand the dynamics of the
human immune system in interdisciplinary applications”) supports my research program, which aims to identify how the
immune system can be rewired en masse to elicit higher-order decision-making while still enabling the system to remain
otherwise “healthy.” To this end, we are leveraging a highly interdisciplinary research team (computational and
experimental immunologists, software engineers, and education researchers) and collaborators to build a Virtual Immune
System -- a multi-scale, multi-approach computational framework to understand better the complex dynamical nature of
the immune system, identify more accurate multi-dimensional biomarkers, and identify safe and effective treatments
within a reasonable time and cost. In addition to expanding the Virtual Immune system, my program continues to develop
methods and technologies for data-driven model construction, visualization, computation, real-time simulations, and
reproducibility to advance multi-scale modeling of the immune system and beyond, including a cloud-based collaborative
modeling software, Cell Collective. Cell Collective is a core technology that enables us to continue to build collaborations
and deepen our existing relationships, including with translational partners to advance the impact of our systems work on
drug discovery, a large international team modeling COVID-19, and with virologists and immunologists to further validate
our computational predictions experimentally. This supplement will enable us to enhance the scalability, robustness, and
sustainability of Cell Collective, which is currently used by thousands of scientists and life sciences students, and
instructors around the world.

Public health relevance
NARRATIVE The proper response of the immune system to pathogens is governed by complex, network-like interactions among various types of cells and their associated communication mediators. The parent grant enables us to work towards the development of a “Virtual Immune System” -- a multi-cellular and multi-scale model of the human immune system -- to study the properties of the immune system, investigate immune-related diseases, and make predictive modeling software technologies more accessible to the broad scientific community (including immunologists, computational biologists, and translational researchers). This supplement will enable us to enhance the scalability, robustness, and sustainability of Cell Collective, which is currently used by thousands of scientists and life sciences students, and instructors around the world.